Activity of Minimal NMDA Receptors

This project will characterize the functional properties of NMDA receptors that lack N-terminal and C-terminal
domains, herein referred to as minimal receptors. These proteins consist of the core machinery of NMDA
receptors and include the extracellular agonist-binding domain (ABD) connected to the ion-permeable pore
formed by the transmembrane (TMD) domain. In the parent project, we were successful in using a structural
model of this minimal receptor to envision the opening trajectory of NMDA receptors, using molecular dynamics
simulations. However, it is unknown whether the minimal receptors are functional and therefore whether they
represent a suitable model for further structure-function investigations, based on the hypotheses generated by
our simulations. In this application, we propose to investigate the hypothesis that minimal NMDA receptors
display glutamate-mediated ionotropy. Our preliminary results demonstrate that minimal receptors respond to
glutamate by producing excitatory currents that differ in kinetics from wild-type receptors. By delineating
commonalities and differences between the activation mechanism of minimal NMDA receptors and native
receptors, results from this project will provide information necessary for the correct interpretation of results from
molecular dynamics simulations.

Public health relevance
NMDA receptors are glutamate-gated excitatory ion channels with essential roles in the central nervous system, whose activation mechanism remains incompletely understood, thus preventing the development of rational approaches for the treatment of a variety of neuropsychiatric disorders. The parent project uses an integrated approach that integrates computational modeling of structural changes that represent the receptor activation reaction and comprehensive testing of the computationally-generated hypotheses with electrophysiological measurements. In this supplement we propose do delineate electrophysiological properties of a truncated NMDA receptor protein that we used successfully to model the gating reaction, but for which functional information is unavailable.